Examining CSF and Blood Biomarkers to Gain Insight into Postoperative Delirium and Neurocognitive Dysfunction

PROJECT SUMMARY/ABSTRACT
Delirium occurs in 10-40% of surgical hospitalizations and has been associated with post-discharge declines in
cognition and function, including Alzheimer’s Disease (AD). After hospital discharge, the incidence of
neurocognitive dysfunction is estimated to be up to 10-25% in the year after surgery. However, pathways leading
to postoperative delirium and neurocognitive dysfunction are not understood. Biomarkers obtained during and
after surgery may provide important insights, similar to how biomarkers are used in AD research. In AD research,
the use of biomarkers has transformed the conceptualization of AD from a syndrome to a pathologic entity. The
AT(N) framework has provided researchers with a clear approach for staging, diagnosis, and monitoring disease,
with several cerebrospinal fluid (CSF) biomarkers, such as β-amyloid, tau, and phosphorylated tau isoforms,
having utility in this framework. The goal of this proposal is to pursue a parallel strategy of examining CSF
and blood biomarkers to understand pathways leading to postoperative delirium and neurocognitive
dysfunction. One hypothesized pathway is blood brain barrier (BBB) injury, followed by neuroinflammation,
and neuron/astrocyte injury or astrocytosis, all layered over heterogeneity in baseline patient vulnerability. Both
animal and human studies support aspects of this hypothesis. However, few human studies have collected
serial measurements of CSF, which is important for brain-specificity. Relevant domains (and associated
markers) that support conceptual models of postoperative neurocognitive dysfunction include baseline risk (AD-
related biomarkers; e.g. β-amyloid and phosphorylated tau isoforms), BBB injury (CSF/blood albumin, platelet
derived growth factor receptorβ), neuroinflammation (cytokines/chemokines, microglial activation), neuronal
injury (neurofilament light, tau), and astrocyte injury/astrocytosis (glial fibrillary acidic protein). The potential of
using biomarkers to understand postoperative brain dysfunction is profound, but there are important limitations,
including (a) most studies have not collected CSF (b) studies reporting associations of biomarkers and delirium
or neurocognitive dysfunction have been suggestive but inconsistent, and (c) most studies have few
postoperative samples (particularly for CSF), a small number of biomarkers, and limited cognitive follow-up. To
address these gaps, we propose a 3-center study of 180 patients undergoing open or endovascular aortic
surgery, who have a CSF drain placed as standard of care. We will obtain serial CSF and blood samples for 2-
3 days. We will then determine whether CSF biomarkers of baseline risk, BBB injury, inflammation, neuronal
injury, and astrocyte injury/astrocytosis are associated with delirium (Aim 1) and neurocognitive dysfunction (Aim
2). We will also examine the associations of blood biomarkers with delirium and neurocognitive dysfunction and
the correlations of serial blood and CSF biomarkers (Aim 3). This study will provide a unique resource of serial
CSF and blood samples to explore how BBB injury, inflammation, and brain injury contribute to delirium and
neurocognitive dysfunction. The results will also provide insight into the utility of blood-based biomarkers.

Public health relevance
NARRATIVE This study will provide an incredibly unique resource of serial cerebrospinal fluid (CSF) and blood samples from surgical patients to examine pathways leading to postoperative delirium and neurocognitive dysfunction, which may have relevance to understanding the pathophysiology of long-term cognitive decline and Alzheimer’s disease. Relevant domains (and associated measurable biomarkers) that will be examined include baseline risk (β-amyloid, tau, phosphorylated tau, neurofilament light), blood brain barrier injury (CSF/blood albumin ratio, platelet derived growth factor receptor-β), neuroinflammation (cytokines/chemokines, markers of microglial activation), neuronal injury (neurofilament light, tau), and astrocyte injury/astrocytosis (glial fibrillary acidic protein). The results will also provide insight into the utility of blood-based biomarkers to identify high-risk patients and optimize perioperative care to reduce postoperative delirium and neurocognitive dysfunction.